FDA FERN Cooperative Agreement Continuation Program (U18)

Project Summary From 1999-2014, the Food Safety Laboratory (FSL), Center for Animal Health, and Food Safety (The Center) at New Mexico State University (NMSU) has worked closely with the Food and Drug Administration (FDA) Office of Field Science on a variety of food safety and defense assignments. We were tasked by the FDA to evaluate, analyze and validate rapid test methods. We have improved many Bacteriological Analytical Manual (BAM) methods and provided validation data for rapid methods that have been implemented by FDA Regional Laboratories. FDA has also distributed improvements in analytical methods to Food Emergency Response Network (FERN) member laboratories. We are directly involved in many of the FERN mission objectives. We provide laboratory outreach with New Mexico State University agricultural programs to growers and food processors. We have demonstrated experience in method development and validation. Through the New Mexico Cooperative Extension Service Programs, we provide training to growers and food processors in food safety and defense. We perform regular proficiency testing and validation with BAM and new rapid test methods. When requested, we participate in surveillance activities. We are a member of the Electronic Laboratory Exchange Network (eLEXNET) Program for electronic communications. We were selected to participate in the FDA Whole Genome Project and have obtained an illumina MiSqe benchtop sequencer and will receive 3 years of supplies to support our sequencing efforts. When we were selected as a FERN MCAP lab, we increased our capabilities and hope to continue to serve the FERN program in detecting and identifying threat agents in food at the local, state, and federal levels and be a service to the nation. As a FERN MCAP lab, we intend to continue to: 1) Develop proficiency in the equipment received from the MCAP 2) Obtain appropriate training for laboratory staff 3 3) Participate in all FDA/FERN activities as requested by the FERN National Program Office (NPO)

Public health relevance
Project Narrative Four Key Project Areas a) Sample Analysis Program and Surveillance Assignments The NMSU FSL proposes to participate in the FDA/FERN sample analysis program and to conduct surveillance assignments as designated by the FERN NPO. The FSL will also analyze samples for pathogens during foodborne disease outbreaks and provide surge capacity for the FERN in the event of a large‐scale food emergency event. b) Provide Analytical Data The NMSU FSL agrees to provide analytical data for potential regulatory utilization through the use of standardized methods, equipment platforms, and reporting methods (standardized analytical work sheets and electronic results reporting). c) Method Development The NMSU FSL will participate in method development, method validation and matrix extension work as determined by the FERN NPO. d) Provide a laboratory for training opportunities The NMSU FSL agrees to provide a laboratory for conducting FERN training sessions. To date, we have hosted six FERN trainings at the NMSU FSL.